Efferocytosis by Bone Marrow Stromal Cells and Bone Aging

Efferocytosis by bone marrow stromal cells and bone aging
Pre-clinical studies show that senescent bone marrow-derived mesenchymal stromal (a.k.a. stem) cells (MSCs)
and osteolineage cells contribute to age-dependent bone loss and bone marrow failure. Therefore, the
identification of novel mechanisms that accelerate MSC dysfunction could enable mechanistic approaches to
degenerative processes that impact the skeleton. While a handful of in vitro studies previously demonstrated
MSCs’ ability to phagocytose apoptotic cells (efferocytosis), matrix, pathogens and metal particles, whether
efferocytosis by MSCs impacts their function and bone maintenance is not known. We found that bone marrow
MSCs indeed efferocytose apoptotic neutrophils in vivo. Preliminary data from adult mice with transgenic
overexpression of the direct phosphatidyl serine receptor BAI1 in MSCs suggest that chronic low dose
enhancement of efferocytosis by MSCs may be beneficial to skeletal health. We also found that, in aged mice,
efferocytosis by MSCs is significantly increased. Moreover, transcriptional and functional preliminary data in vitro
suggest that excessive efferocytosis by MSCs decreases osteoblastic differentiation and promotes senescence.
Since efferocytosis is accompanied by oxidative stress and mitochondrial changes, which we previously found
to modulate osteoblastic differentiation, mitochondrial disruption may mediate functional changes in MSCs that
clear high numbers of apoptotic cells. Based on these data, we hypothesize that phagocytosis by MSCs is an
important component of osteoimmunology; however when pathologically increased in aging, it causes MSC
oxidative stress, mitochondrial dysfunction and senescence, thus contributing to bone loss. To test this, using
aging and genetic models, we will 1) determine the mechanism of MSC efferocytosis; 2) define the pathogenic
mechanisms induced by efferocytosis in MSCs; and 3) establish the role of efferocytosis by MSCs in normal
osteoimmunology and in aged bone. Defining the role of facultative phagocytosis/efferocytosis in metabolic
changes and senescence in MSC and their relevance to human aging and disease will provide innovative,
actionable strategies impacting degenerative disorders that target the skeleton.

Public health relevance
Narrative This project is relevant to public health because it addresses a novel mechanism of mesenchymal lineage dysfunction and bone loss in aging. If successful, it will provide a scientific basis for development of new strategies to prevent and/or treat bone loss. It is also expected to advance the field of bone biology by elucidating yet unknown mechanisms connecting phagocytic activity of mesenchymal stromal cells, subsequent metabolic disruption, senescence and their dysfunction leading to decreased osteogenic capacity and bone loss. This is highly relevant to the NIH mission of developing fundamental knowledge that will help to reduce the burdens of human aging and disability.